Training and Development of Outstanding Surgeon Scientists

The 5-year pilot program will support a total of 36 early-career surgeon scientist program participants, each of whom will receive three years of funding in three cohorts of 12 Participants per cohort, staggered a year apart. Funding of up to $125,000 in direct costs will be provided annually for extramural grantees, to support 6 person months effort of the participants and other allowable costs including travel and support for research training activities. The participants will be funded through an administrative supplement to the grantee's NCI-designated Cancer Center Support Grant (P30) or Comprehensive Partnerships to Advance Cancer Health Equity (CPACHE; U54) to one of the institutions serving underserved health disparity populations and underrepresented students (ISUPSs); see budget below for details. Each cohort will be comprised of primarily extramural surgeons. NCI Intramural surgeons are also eligible. Only one candidate per P30, one ISUPS candidate per CPACHE U54 Program, and one candidate per intramural NCI Branch may be nominated to apply by the Center director or Branch Chief per cohort. Curriculum NCI will sponsor quarterly professional development symposia to include grant writing seminars, content area mentoring, scientific methods curriculum and more. Diversity, Equity, and Inclusion Additional announcements of the program to underrepresented minority surgeon populations will be made through collaboration with external organizations, such as professional surgical associations. Diversity, equity, and inclusion should also be a factor in recruiting mentors for the Participants to ensure that the ESSP community reflects these values. ESSP-Participant Milestones Second and third years of funding will be dependent on achieving sufficient progress towards milestones that are appropriate for the Participant's career stage. These milestones include: 1) acceptance of either an abstract at a society meeting or a manuscript by a journal; 2) submission of an NIH grant application; 3) submission of a non-NIH grant application; 4) participation in all professional development sessions offered by the ESSP. Intramural Physician-Scientist Early Investigators will be expected to submit an internal NIH proposal and a non-NIH grant. Evaluation Metrics The pilot program will be evaluated annually for outcomes, by administering participant surveys, conducting exit interviews of Participants completing the ESSP, and collecting academic activity from participants and alumni.